Elucidating the mechanisms by which the extracellular matrix contribute to gastroesophageal cancer pathobiology

ABSTRACT
Gastric cancer (GC), the third leading cause of cancer death worldwide, is characterized both by
histologic and molecular criteria. The two most common forms include Diffuse GC (DGC) and
Intestinal GC (IGC). Each class of GC is associated with early inactivation of a distinct tumor
suppressor, DGC with CDH1 (encoding E-cadherin) and IGC with p53. Beyond genetic changes,
gastric cancer development is promoted by environmental factors, specifically Helicobacter
infection and exposure to dietary nitrates. We posit that addressing two fundamental questions
in the gastric cancer field, defining the cells of and defining the distinct mediators of progression,
should be addressed together given their interconnectedness. We will evaluate the interplay of
genetic and environmental precipitants to gastric cancer using novel engineered mouse models
where we can selectively target key tumor suppressors in the gastric epithelium in concert with
relevant exposures. We will then deeply interrogate tissues with the combination of multi-omic
single cell technologies enabling dual analysis of gene expression and chromatin accessibility in
individual cells and the subsequent use of spatial transcriptomic tools allowing us to map features
of individual cell types spatially to refine the cellular origins of these altered cell types. In concert
to defining cellular origins of the two primary classes of gastric cancer, our integrated multi-omic
and spatial analyses will be evaluated to define changes in cellular programs and candidate
mediators of these altered phenotypes. Furthermore, we can define the interaction of
environmental exposures in gastric tumorigenesis. Subsequently, we will perform functional
validation of candidate mediators of progression, evaluating both features intrinsic to gastric
epithelial cells and those emerging from the microenvironment. These studies will both address
longstanding debates over origins of these cancers and define new targets to prevent cancer
development.

Public health relevance
PROJECT NARRATIVE We will integrate novel mouse models, organotypic cultures of human and mouse cells and state-of-the-art single cell profiling and spatial transcriptional data to address fundamental questions regarding the cell of origin of distinct classes of gastric cancer. In parallel, we will define key transcriptional mediators of the progression to gastric cancer and then perform experimental validation. Together these studies can integrate addressing longstanding debates over origins of gastric cancer while defining targets to prevent cancer initiation.